HSV 007--SKBS HSV VACCINE TO PREVENT GENITAL HERPES IN HEALTHY SUBJECTS

To compare with placebo, after the full vaccination course, the protective efficacy of fD-Alum-MPL vaccine to prevent genital herpes clinical disease.